Berkeley Training Program in Genomics and Computational Biology

Project Summary/Abstract
The GTP provides graduate training and research opportunities at the University of California,
Berkeley, emphasizing the cross-disciplinary nature of this rapidly advancing field. The trainees
and training faculty are drawn from Ph.D. programs in diverse departments and graduate
groups, associated with a campus-wide Designated Emphasis that formalizes the requirements
for a broad education in computational biology and genomics. The program has three principal
thrusts: population and evolutionary genomics, functional genomics, and computational and
statistical methods. Trainees will take advantage of a rich training environment of seminars,
retreats, and group meetings as well as a diverse set of formal course offerings that range from
introductory to advanced methods in genomic biology. Research training will typically begin by
the end of the second year, following an introductory period of laboratory rotations,
coursework, and preliminary examinations. Progress of the trainees is evaluated by annual
thesis reviews and regular meetings with mentors. The Program will train between six and ten
predoctoral students per year in genomics and computational biology.

Public health relevance
Project Narrative Genomics is revolutionizing approaches to human health, from the design, analysis, and interpretation of clinical studies to the exploration of the fundamental biology underlying the human condition. Our interdisciplinary training program will develop the next generation of genomically and computationally sophisticated scientists and engineers.